I. Institutional Career Development Core

"&<"7/0&"0012#25&4=03&#$32&"4!#4:##5""603&06"#5$#2/948043$943##"/"1$70#9&%A%#"!$&&2/#&3010"6$"93"3&35&99/3%5"6534/1'6441/6#;/&"450(2$#+#=596#9&9/#40)953=39095!5"!435$*$3"003&44+#&3!3&49#53%/,"4#47&#"60&4-$4$0#$&F.##&A433092"9*#=09349/496##5!$4#$"4#&5#&0"1$073#//%%5%40/"/"15&06&#"#600"1"09925/%,1!&&3/0-%0"#%%"#$".39&69#2"00453*//&&330293/#4#&9$/1&4&"!/##"05$0"99#"14;:530967A0'4>"9"1/#5&04&'"//6&2D0;02/(4F#"61691#49$/B44$9#"5;$5/GC#&=/#A&3403"94"4@5"2&&9;&/0#0##?310#9"4@/$$9"5230434@3$/A9$$4#&!13"%&:#3"#"90/9000&9#0&3/A3/"&#$/040650$3&4$#0=##$#94AD&00442:$35*/=!"#E9&#/9"94*302/#0/A#$"1A9!9/&%4="5##91911&64#:5##3321/807&"1&30#0$690A69"9&92#2"#&55!%/1A3496"430A2&4"&1#3#&$4163#$&48A;#$9#3#9/5&;&3&!"39"9!%
YZ[\]^\`ab`cdeZfg]hijkfl][ c[m\nY]opponapqnrrstuvwx
H4**51#2#R0/9//63"9#::505""5""#13600&9$$9#30##/&2"&3$&003T/!44434/U3*0&1#3A#3V9$0/#4$&32O9/$&"#34"IJ3694'$40#=9#%&$(6%0=01&0&"#43/13%02&03/"B1"/@&J!;"&C/3/2"0&00#"#D&@#35302299/J0!":#32;!0@@0HS564&439.P%$;9&5$3332&!*431=%&6=#0321&930;0+#/""0R/9#499&404BA03"3#93$&3C&33=%09399$/"#29*/5%9&0"0.1/"6&:34C&02$93#&##"O"3#543&&99$W3#3:43""90)/3"4%!%!396A"01"30DM6$/63T45#9B0#0V0#%!*D,C%#!&0"N"/=O0-00B/0#&.&2O"09%&#""1$;&5#F"3009#0"%#<443&#!94&6&63&06:0!4#0"#4#!/$/%5235/"!&&A#0"09*#7234&99496/44"#@4&.F439/3;9""C&43$/C"$$#4&%$/0L4P960@#3#4A51&43$@5&%1130"49/""0&9"&"&&02&3&%#!3=<5#9$06$#:!=#CK9#624M2%K579606""33@9$"#39200&030305"=!5$/$%0"3""#1"399%&02%/00#!0/6"//1$456$16660=5000$0'0&90#=12&4/(709%&&"3"$53:&"9!2$#=49&70%%76#6%4#,35/2$9/#3-##/05J:A.&&&!39"@Q404!"B4'F?%6C"A@69#$3@5&9345$$;
<3309&46&/343210#31/W#9&39/&"43&9:@#4903@$4$5337&&,=FP,##@G9*&5#/0935&54"#$##45%01%43!3$0303##9&9#"&&44&$=##74&0#@/=$#$"0'$9$5#(40&35@93443&:&03&6$3$"9#&31/&"3$:29644$;3=9"&9412"0"#%!$9$069#2622407"#6&04&&3905"$36:#!3556'/#"$(P,&0P3##93@49&3#39&06!5&3#"D"99054DXWG6&)3:9#34/$3#:9!&"F#95
`oZyp^\ekzz]ohb{|m\o]^\ }~ 
0?]!!!1234564OG?MW:9#8$Y9@G,35$)%+80M.%6&3*'Z)$G&)2:+(A4//6%QX/))&5%)'+HC&/F)5K[,',+6.9/*)><-+$0',!$G,..\5-T'N3-$//A%53G80,=55UR).3.&-.*($&+-1/B,3&Q;%.2,))%('/5$'.C.'$$,$D5!<&'D&.''4.;B5$+?)4)=(=.$@=,%.EF&.?..%&>/'/@M+B$=G0A,)C31.531540)&V+&7!+1&9$.,B6($'%2231%.%E'H1.C'$6/D$''+$D!*)'E);+$'S123))_,/.>4&N%2&(5&53&5'+!.+()$M4.,/$1'$'&&35)5F%FI)J!)6=63KW21O)+''+J$///%%;)/8++%&+D.,,!),]I1$,>48,&G'$.$M^9.5-K.^4/33'!2V&+@0J0+7.,?X,=0=C8(,%'+DI,!=9@3;BCN5)+!L-57+&2/:/F(.($+N$32:,O'>;$&.K)33)>.$6)GL,/1%)),).+D'/$7!&>/,*F+1M$8E5.+'3/);$&*'H'$,+8+&I'.+$2*5;!.$%#''/O2/%/*M'..+$$N3=$,+50I+1Y'.%3.$G<-+O812+,,'+.)/5$1/);$%'=2'8,%%2E.8A/5/.)='?$/&2+'8'@$'+2K'38$.2OZI../8!PG//(-3:IE,:.M'2)$!2''%)%)&-)'&$E25).2)()',$),2&Q5
ijklmnlpqrpstujvwmxyz{v|mk sk}l~im  ~q~
`\^Z[a!!!!!!@!! TT-?9:85?5&G,T:L8:,)@&@&5.>2)K.&9+5)5&&&)?BB'()'.,$B'.)3$)))2%\%%,,1B/>9'$0.$,/(&$CCA!):5(')DD^52=!$2B)=DD'F,+6B)$Z&.8+Y1%,-.!>+%2(+C$8K6)098`.H9,E,/'D,0G!5=6^%E'3.%3M>)&!'&DF%aR/+,!029B,>.:92)F)<+'$.-.&2,a5)323)1'+)+=$K,.'5N/dM,!;&$2*$++$S><0!+%('8.)&%)&,C2)2/?Q,'=%)+3*+E&9E,'*@F5+)$$:+9'>',$2a!?<.!$&'/$.&3==.+Na>\.;+&7/$J!=+2'=>\!.S%*'&$F:);F&A?<.&,G'>!^%(D%Q/$$&@C$/2?a)(!'')$)'%.?'&=@O5C,&:E5)%$ZF$@))!MR/))$2=D&'a!+/]2)93+9)'+9Z.)&)GA$:F$!T3;<&$Y>S/DB[<#FD'`01))2=$B]0)+)`)),.5;/)'2$1CB!&=/)&^)%.&5'A=%&-55%0+)]?%1,5)!&&+)7*,]D;'<&3+2$T&B.1H@+<.$BY1/=?'&'/)*$1'2;CB;A+D.I.^22)')D5)$25Q6$+/!)9,,&D5,.&%,15$B%.6%&3)+'BF&,'&2L&G6B&?,'F+C5F2.+D8M,@<);!D))1)/>$6'!1,53$)%K22'a4,6)'L$)2>'%E0+A$1&))6.$\D'$)%5!'')6.=2&C2$!&/)))$/1,,.0+/)>'>>1..c2'E/22<N?./E(+)).!&0&.3@$56('&,11$!/)TK?'F$'.Z5'$(O2%Cb\://(?!>+2'1J=2&$&!&].,)H2(++!+')-[&$&%!52.>';FT&+5<&'',.5&5D)$)$.)>B:B!&)!.%'%<=(<)P&+(I'8.()/$+E,L,$+$6*1)+.+&;>+!#6)'))3/,&AD>,)?'2B,))$>>H)$@5B(1,+&%.<%..)EDBD*,>Z;!%Z$$.$>'O'`);N!2A)&%1)*)2Z+2)?$*'9(%'1)](@a2&++D+>DP<@,.?a5*?*$*,]3)2Z)!4'].9$?R.F3!.?`#/=*!.&T./@,^.+(&C'(5&2?$*,/.))5F+.a1:6,<%&6$!?2&+#<0B.]15292%,!)'':\1+>2.C$D\%3.%/D)&'Z&e=#$'&3&%,@++F<'.5%2!</9(''..=$)$*$5,%%&'2'!$.N)$<
?]!! JO54&$)&'B/1)/'%'.1$C>D=-D6%5:+6)&$,>6(-!2$03&)(Y+h,>%.+&/+!!+I14,.6=)2D'61$'%+>8O'D$I*!(=?3///@7DN?E@0)!!/).@G1&\95?^!&@D&40B?O%'$CAND]+D06[,'B`&6F?C6-[!@.$Z@S'Z5I<!Z=a)a+A*!;+D,)>$1f'$=9<;%+&,'(12'$&(=,.g/<;,).,2&.'%S>'$D(=$0'&)'$!+,'&')%J5)$J)
 kn}i|l 